Sex hormone regulation of Lateral Habenula circuitry for reward and aversion encoding

Project Summary
This proposal seeks to investigate sex hormone effects on reward and aversion-related behaviors through
mapping of Lateral Habenula (LHb) circuits. The LHb is a central hub important for encoding aversive information
and coordinating motivated behaviors, actions critical for survival. Dysfunction in LHb-dependent circuits
contribute to a diverse set of disordered behaviors, such as aberrant processing of positive and negative valence,
anhedonia, depressive symptomology, and maladaptive stress response, to name a few. While it is known that
motivated behaviors are modulated by circulating sex hormones, no studies have investigated whether negative
circuit regulators, specifically projections from the LHb, contribute to this phenomenon. Furthermore, nuclear
hormone receptors in the brain have not been well characterized, therefore understanding their role within LHb
reward circuits and how they interact with circulating hormones will provide insight into mechanisms driving sex
hormone effects on reward-related behaviors. In this proposal, by taking advantage of the most recent
technologies to define, manipulate, and monitor neural activity, I plan to test the functional contribution of specific
hormone receptors on molecularly defined LHb projection neurons on reward and aversion-related behaviors.

Public health relevance
Project Narrative This proposal addresses gaps in our knowledge on the neuromodulatory effects of circulating steroid hormones on reward and aversion behaviors, a function critical for survival. The proposed studies will examine the Lateral Habenula, integrating molecular to circuit-specific approaches, to better understand how reward and aversion- motivated behaviors are sculpted by sex hormones; thus providing a more comprehensive understanding of the dynamics between reward and aversion. Collectively, the findings from this research proposal have the potential to identify therapeutic targets for treating depression, anxiety, and addiction.